Assessing and Enhancing Survivorship Care in Adolescent and Young Adult Cancer Survivors

Project Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-CA-
24-041"
There has been a growth in the number of cancer survivors across all age brackets, but particularly adolescent
and young adults (AYAs) who experience poorer survival relative to pediatric and older cancer survivors.
AYAs, even when cured from their cancer, are at an increased risk of excess morbidity and mortality,
attributable to higher rates of treatment-related health conditions, including subsequent malignancies and
cardiovascular disease. AYAs also have unique survivorship needs and are particularly vulnerable to gaps in
care related to lack of knowledge of late effects, loss to follow up from the primary oncology team, lack of
regular primary care, and the need to navigate critical transitional life milestones. Growing recognition of
survivorship needs has led to the development of standardized, cancer survivor-specific screening and
surveillance guidelines, with the goals of risk reduction, early detection, reduced mortality, and improved
quality of life; it has also led to the establishment of National Standards for Cancer Survivorship Care. Despite
the availability of these guidelines, receipt and overall quality of survivorship care is inconsistent across
survivors and treating facilities, with gaps in our knowledge of survivorship care to meet the unique needs of
AYAs. In response to NOT-CA-24-032, we propose a mixed methods study of AYA cancer survivors (ages 15-
39 years at diagnosis) diagnosed between 2014-2019. In aim 1, we will Identify risk factors for underutilization
of survivorship care in AYA survivors and assess alignment with National Standards for Cancer Survivorship
Care by linking EHR data of AYAs within our cancer registry with an online patient survey to identify what
proportion of survivors have a documented survivorship visit (primary outcome) and identify risk factors and
perceived barriers to receiving survivorship care across patient socio-demographics and health behaviors. In
aim 2, we will conduct focus groups in a subset of AYA survivors who are high and low utilizers of survivorship
care, along with key informant interviews with stakeholders in order to understand the current landscape of
how national survivorship care standards are implemented, to identify factors driving under- versus high
utilization of AYA survivorship care, and to develop priorities for enhanced survivorship care that directly
address patient-driven approaches for reducing barriers. The results of the proposed research have the
potential to inform strategies to optimize AYA survivorship care and its utilization, to identify demographic and
geographic utilization differences, and to inform future survivorship care interventions that promote high-
quality, equitable, and sustainable use of survivorship care among AYA cancer survivors.

Public health relevance
Project Narrative Despite the availability of guidelines for cancer survivorship, including the newly released National Standards for Cancer Survivorship Care, receipt and overall quality of survivorship care is inconsistent across survivors and treating facilities, with gaps in our knowledge of best practices for delivering tailored survivorship care to meet the unique needs of adolescent and young adult (AYAs) cancer survivors. Within this proposal, our team will conduct a mixed-methods study of AYA cancer survivors (ages 15-39 years at diagnosis) diagnosed between 2014-2019, using cancer registry data linked with electronic health record (EHR) data and patient surveys, and supplemented by focus groups and key informant interviews with stakeholders. Our primary goal is to understand the current landscape of how national survivorship care standards are implemented, to identify barriers driving underutilization of AYA survivorship care, and to develop priorities for enhanced survivorship care that directly address patient-driven approaches for reducing these barriers.